UTILIZATION OF QSTAR MASS SPECTROMETERS, LC SYSTEM & ASSOCIATED SOFTWARE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Utilization of QSTAR-XL, QSTAR-Pulsar, and QSTAR Elite Mass Spectrometers and related data workstations.